The Goizueta Alzheimer's Disease Research Center

SUMMARY/ABSTRACT: LIFESTYLE AND EMPOWERMENT CORE
The Lifestyle and Empowerment (L&E Core) represents an exciting expansion of research into lifestyle risk
factor identification and management at Emory’s Goizueta Alzheimer’s Disease Research Center (GADRC)
which aligns with the national call to increase support and research for individuals and families facing
Alzheimer’s disease and AD-related dementias (AD/ADRD). The National Alzheimer’s Project Act (NAPA)
recognizes that lifestyle risk factors are critical to understanding AD/ADRD pathology and resilience and that
there is an urgent need for interventions aimed at reducing lifestyle risk factors, especially in individuals from
under-represented groups who are at higher risk for AD/ADRD. NAPA’s call to “Accelerate Action to Promote
Healthy Aging and Reduce Risk Factors for AD/ADRD” has been directly addressed through the GADRC-
affiliated Cognitive Empowerment Program (CEP). The CEP is an innovative research program that delivers
structured lifestyle interventions and provides educational resources aimed at slowing or preventing cognitive
and functional decline and reducing the impact of mild cognitive impairment (MCI) on quality of life. Over the
past four years, the CEP has been successful in using innovative digital technology to evaluate lifestyle
biomarkers for greater precision in identifying, monitoring, and managing disease progression, developing an
evidence-based lifestyle and empowerment curriculum for MCI, and implementing flexible service delivery
models that reduce participation barriers. This is a solid foundation for establishing the L&E Core, which will
provide opportunities to expand reach
beyond MCI to include healthy aging, individuals with asymptomatic AD
and those with non-AD and mixed etiology dementia. The L&E Core will play a crucial role in increasing access
to targeted tools and methods for assessing and reducing lifestyle risk factors in ethnoracially and etiologically
diverse populations and supporting collection of harmonized lifestyle metrics across GADRC Cores and
GADRC-affiliated research and clinical programs. The Specific Aims of the L&E Core are to 1) Harmonize and
scale behavioral and digital tools to expand lifestyle risk factor assessment and support enhanced phenotyping
across the GADRC; 2) Improve precision in lifestyle intervention delivery and research for diverse populations;
and 3) Promote education on lifestyle risk factor management for diverse populations. Achieving these Specific
Aims will enable the L&E Core to advance the GADRC and NAPA’s shared goals of slowing or preventing
cognitive and functional decline in AD/ADRD by increasing research into identification of lifestyle risk factors,
providing culturally-appropriate and disease-specific interventions and education to address disparities in risk
factor reduction, and accelerating translation of research into clinical practice.